Harnessing commensal redox metabolism in infection prevention

Abstract: Many gut-infecting bacterial pathogens undergo growth expansion in the gut lumen as
part of the virulence, and as supported by their underlying metabolism. Commensal metabolism
in the gut provides an opportunity to impede these processes by depriving pathogens of growth-
promoting nutrients. Using the amino acid and carbohydrate-fermenting pathogen Clostridioides
difficile, we will evaluate how redox metabolism of target carbon sources by the pathogen and
commensals can enhance or limit its ability to colonize and infect the gut. Analyses will leverage
innovative approaches to track nutrient flow among pathogen, commensal, and host tissues.
Studies will further perturb host environments using carbon sources that are fermented by the
pathogen, protective commensals, or both, to assess their role in disease pathogenesis and
progression. Findings will inform small molecule and bacteriotherapeutic interventions in disease
prevention and treatment.

Public health relevance
Narrative Gut bacterial pathogens need to obtain nutrients to colonize and infect intestinal environments. The consumption of preferred substrates and micronutrients by commensals offers opportunities to target critical events in pathogen colonization and infection. The pathogen Clostridioides difficile has a diverse metabolism that supports gut colonization. Using target fermentable substrates metabolized by protective commensals and/or by C. difficile, we will evaluate molecular mechanisms by which target fermentable substrates interact with the host, pathogen and commensals to modulate critical events in pathogen colonization, infection, and resolution. Findings will be evaluated in conventional mouse models to inform targeted approaches using small molecule, bacteriotherapeutic, or combined approaches to mitigate risks for these infections.